2023 Inhibition in the CNS Gordon Research Conference and Gordon Research Seminar

Project Summary
The next Gordon Research Conference (GRC) on inhibition in the Central Nervous System will be convened at
Les Diablerets, Switzerland, on July 16-21, 2023. This international research conference has been held every
two years since 2005 as part of the GRC conference series. As in previous years, it will be preceded on July
15-16, 2023, by the Gordon Research Seminar (GRS), which provides a unique atmosphere for junior
scientists, including postdocs and graduate students, to discuss and exchange novel findings and ideas in
preparation for the GRC. Inhibition in the Central Nervous System is mainly driven by the neurotransmitter
GABA, which has been proven to be fundamental for brain function and, when the perturbed result in
dysfunction. The GRC will provide a major forum where leaders in the field and junior scientists who are rising
new stars will have the opportunity to exchange novel concepts and approaches to advance the field. The
general scientific goal of this meeting is to explore leading topics in the field of inhibition in healthy brains and
to better understand the role of altered inhibition in neurological and neuropsychiatric disorders. To achieve
this goal, the meeting will pursue the following specific aims: to select speakers that will discuss cutting-edge
fundamental research questions in inhibition within health and disease, to increase diversity and promote
network collaborations, and provide training, networking and career promotion of graduate students
and postdocs. The meeting will attain these aims by selecting 34 world-class speakers and 9 discussion
leaders, many of whom are junior group leaders from 13 different countries (20 US-based scientists, 17
women). There is growing evidence linking GABA deficits to neurodevelopmental and neurological disorders.
As such, the GRC/GRS meetings' emphasis on health impact will maximize discussion of fundamental
questions in this field and seek novel therapeutic targets of inhibitory circuitries to treat devastating brain
disorders.

Public health relevance
Project Narrative The 2023 Gordon Research Conference on Inhibition in the Central Nervous System will bring together top international leaders and junior scientists with the goal of generating an inclusive environment to discuss the latest research and advance our knowledge in the field of inhibition. Particular emphasis will be placed upon linking cutting-edge fundamental and translational science, including research in humans, while promoting gender balance and enhancing diversity in all components of the conference. As such, the scientific program will serve to strengthen existing knowledge, foster new ideas and collaborations, and as such will be ideally positioned for the training of a new generation of young scientists in the field.